Biomedical Computation Graduate Training at Stanford

DESCRIPTION (provided by applicant): Stanford University has a strong record of training both the biomedical sciences and in computer science/engineering. The new NIH roadmap stresses the importance of training the next generation of scientists with quantitative and computational skills. With the increased demand for scientists with credentials in biocomputation, we have an opportunity to increase our capacity for training at this intersection. The Stanford Center for Biomedical Computation has participating faculty from the departments of genetics, structural biology, biochemistry, medicine, radiology, mechanical engineering, electrical engineering, bioengineering and computer science. It is affiliated closely with the interdisciplinary training program in biomedical informatics. In our first three years, we have successfully created a culture of biocomputation science that crosses across these fields, so that students can get dual-training in computation/informatics as well as in their primary discipline. In this proposal, we outline a proposal to continue this training grant, in order to increase the impact of computing in biomedical research. We target biocomputation students working broadly in six areas:: (1) structural and functional genomics, (2) biomechanical simulation, (3) computer assisted interventions and robotics, (4) image acquisition and processing, (5) computer-assisted instruction and networked education, and (6) informatics, data modeling, and statistics. In addition to dual research mentorship, training mechanisms include cross-disciplinary courses that teach fundamentals of biomedicine to technical graduate students, and teach fundamentals of these technical fields to biomedical graduate students. We also have symposia and journal clubs designed to encourage transfer of knowledge between biomedical computation students across disciplinary boundaries. The creation of a biocomputation laboratory on two floors of the new Clark Center for Biomedical Engineering and Science further serves to create a coherent community of biocomputation scientists at Stanford. The training grant will therefore fund disciplinary degree graduate students for an average of 3 years, and provide mechanisms for creating a cadre of young, well-qualified scientists equipped with the quantitative and computational tools needed to tackle the scientific challenges that arise in the 21st century.